Administrative Core - Supporting the National Center of Excellence

The Administrative Core of the renewal of the Brandeis/Harvard Center to Improve System Performance
of Substance Use Disorder Treatment will provide the organizational and administrative structure to ensure
interaction and collaboration among the multidisciplinary investigators involved in the Cores and the
Component research projects; monitor ongoing progress of the Center; identify activities that need expansion
or reduction or require additional or reallocated resources; facilitate outreach to potential stakeholders,
collaborators, and audiences; and facilitate synergies across the Cores. For this renewal, we will build on and
enhance a successful Administrative Core structure and approach used in the current Center. The two Center
Directors, Dr. Sharon Reif and Dr. Haiden Huskamp, reflect a partnership between the two institutions
(Brandeis University and Harvard Medical School). They will share the responsibility for the overall
coordination and development of the Center and for providing the vision and leadership to position the Center
as a productive national resource for research that continues to inform policy and practice focused on delivery
and payment system innovations. The Center Directors will convene the Leadership Team, which will provide
the main locus of coordination within the Center and is comprised of all Core Leads; each Component research
project PI also will be a Core Lead so these projects are each represented. The external Scientific Advisory
Board (SAB), composed of researchers, experts, persons with lived experience of substance use disorder, and
other stakeholders in a range of fields, will provide objective advice on and assessment of Center priorities and
activities, current and emergent research, and dissemination and communications approaches, as well as
facilitate access to avenues for dissemination. The Administrative Core will dovetail with the Research Core,
which will conduct the research; the Policy/Dissemination Core, which will interact with stakeholders for
bidirectional engagement with the Center’s research and findings to advance policy and practice and conduct a
range of knowledge translation activities; and the Pilot/Mentoring Core, which will develop and support the
Center’s mentoring, networking, training, and pilot paper activities.
The aims of the Administrative Core are to: 1) set priorities for the Center, support Center activities, assess
quality of Center products, and develop synergy; 2) promote collaboration within and outside of the Center and
facilitate interaction with the SAB and consultants; and 3) manage administrative aspects of the Center,
including data resource oversight, evaluation of Center impact, and a communications strategy that promotes
ongoing engagement, translation, dissemination, and other efforts to enhance visibility of the Center, aspects
of its theme, and the Component research projects. This Core will be distinguished from the other Cores by its
focus on the management aspects of the Center. Its role is critical to the success of the Center, and it will
facilitate the advancement of the science related to the Center’s research.